A prophylactic vaccine to prevent colonization by Pseudomonas aeruginosa

PROJECT SUMMARY
Vaccination is the greatest public health achievement of our time. With an explosion of antibiotic resistance,
new vaccines against multi-drug resistant (MDR) bacterial pathogens are more important than ever.
Pseudomonas aeruginosa (Pa) is an opportunistic human pathogen that causes severe infections in patients
with cystic fibrosis (CF), burns, severe wounds, pneumonia, as well as critically ill patients who require intubation
or catheterization. Clearing Pa has become problematic as it has become increasingly antibiotic resistant. This
is exacerbated by the fact that the biggest risk factor for negative outcomes associated with MDR Pa is advanced
age. After 60, there is a significant increase in morbidity and mortality resulting from MDR Pa. While there are
Pa vaccines in development, none are licensed.
Like many Gram-negative pathogens, Pa strains of the PAO1/PA14-clades possess a type III secretion
system (T3SS), a virulence factor that allows avoidance of host innate immunity and is required for the onset of
infection. Structurally resembling a molecular syringe with an external needle, the T3SS apparatus (T3SA)
provides an energized conduit from the bacterial cytoplasm into the host cell for transporting effector proteins
that mediate key aspects of infection. A needle tip protein and the first of two translocator proteins localize to the
distal end of the T3SA needle to mediate host cell contact. These proteins, PcrV and PopB, respectively, are
required for pathogenesis and are 95-98% conserved among Pa. We have fused PcrV and PopB to give PaF.
After demonstrating the protective efficacy of PaF, we genetically fused LTA1, the active moiety of labile toxin
from ETEC, to the N-terminus of PaF (L-PaF). L-PaF reduces mouse and rat lung burdens significantly. When
compared to PBS-vaccinated mice, L-PaF-vaccinated mice possessed significantly higher OPK activity in the
sera and elevated levels of IL-17 were secreted from lung cells. Recently, Pa outliers have been identified that
are devoid of the T3SS entirely and use ExlA to disrupt host cell membranes. Thus, we have added ExlA to our
L-PaF (L-PaFE) emulsion and have demonstrated protection in PAO1/14/7 clades when delivered intranasally.
Furthermore, we have added BECC438, a novel monophosphoryl lipid A (MPL) biosimilar (a TLR4 agonist), to
increase OPK activity (L-PaFEB438). The goal of the R01 is to continue to develop our broadly protective
Pa vaccine formulation by assessing the protective immune response in rodent models. Knowing the
vaccine efficacy and immune response in these models will allow us to finalize the vaccine formulation and the
demonstrate the potential utility of that formulation in humans.

Public health relevance
PROJECT NARRATIVE Pseudomonas aeruginosa (Pa) cause severe infections in patients with burns, severe wounds, pneumonia, or undergoing nosocomial procedures. Most Pa strains are resistant to many antibiotics limiting the treatment options. Vaccination is perhaps the greatest health advancement of our lifetime. Our vaccine to prevent Pa, regardless of initial injury or Pa strain, will positively impact all of us. Indeed as we age, we all have a greater risk of a potential Pa infection. Our vaccine is aimed at preventing these infections as well. Herein we examine the vaccine formulation for efficacy in rodent models.